The Role of Vimentin Cytoskeleton in the Mechanobiology of Schlemm's Canal Endothelium.

Project Summary The bulk of increased resistance to the outflow of aqueous humor in glaucoma occurs at
the vicinity of the inner wall endothelium of the Schlemm’s Canal (SC). The giant vacuoles (GVs) and pores
associated with the SC endothelial cells are the only open spaces for the aqueous humor to enter the canal.
Thus, they are thought to play an important role in regulating outflow resistance. GVs form in response to a basal
to apical pressure gradient that subjects SC cells to substantial deformation. The extent of this deformation is
mediated by SC cell mechanics. We recently discovered that the elevated outflow resistance in glaucomatous
human eyes is associated with the increased stiffness of their SC cells in situ. These observations render SC
cell stiffness a key factor in GV formation and outflow homeostasis. Yet, little is known about the mechanism(s)
that regulate the biomechanical properties of SC cells and GVs. We previously showed that SC cells become
stiffer when cultured on stiffer substrates in vitro. We also recently showed that glaucomatous SC cells and their
underlying extracellular matrix are stiffer than their healthy counterparts in situ. These findings suggest that the
mechanical properties of SC cells are substrate dependent. In this project, I aim to examine the role of the
vimentin intermediate filament (VIF) cytoskeleton in regulating the biomechanical properties of SC cells and their
associated GVs. The reasons for my interest in VIFs are twofold: first, they are shown to be major contributors
to cell mechanics in general, they are the dominant determinant of cell mechanics at large deformations, and
they have a substrate stiffness dependent assembly state; secondly, VIFs are highly expressed in SC cells, and
it has been shown that they associate with GVs in situ and also impact their life cycle in vitro. To examine this
role, I will first knockdown vimentin in cultured human SC cells and use atomic force microscopy and traction
force microscopy to establish the role of VIFs in SC cell stiffness and contractility. The findings from these studies
will be used as a basis for additional studies employing super-resolution imaging, biochemistry, and
microfabrication to determine how substrate dependent expression and assembly states of VIFs in SC cells
affects their stiffness and contractility. I will next investigate the role of VIFs in GV formation through ex vivo
perfusion of eyes from wildtype and vimentin knockout mice followed by characterizing and comparing the GV
size and density along their SC. I will also determine the impact of the presence or absence of VIFs on the
generation of outflow resistance by measuring the outflow facility in these eyes. Finally, I will knockdown vimentin
in normotensive mouse inner wall to determine the feasibility of targeting VIFs for modulating outflow facility. I
will then extend this method to ocular hypertensive mice to gauge the effectiveness of this approach as a novel
treatment for glaucoma. Through examining the contribution of VIFs to the biomechanics of SC inner wall, I seek
to transition into an independent career in order to investigate the mechanical basis of increased outflow
resistance in glaucoma and to develop novel therapeutic approaches for the disease.

Public health relevance
Project Narrative The elevated eye pressure in glaucoma is a result of increased resistance to the outflow of the aqueous humor into the lumen of Schlemm’s Canal. The extent of outflow resistance is associated with the cytoskeletal mediated stiffness of Schlemm’s Canal endothelial cells as these cells have to substantially deform to create the openings required to drain aqueous humor into the canal. I will determine how a major cytoskeletal system in these cells, namely vimentin intermediate filament cytoskeleton, contributes to the mechanics required to form the necessary openings, and thus generation of outflow resistance.